Engineering CD4+ T cells to develop a novel immunotherapy for pancreatic cancer

Project Summary
Pancreatic ductal adenocarcinoma (PDAC) remains one of the deadliest forms of cancer, with a dismal 5-year
survival rate of only 13%. Despite advances in cancer immunotherapy, the efficacy of adoptive cellular therapies
(ACT), including chimeric antigen receptor (CAR) T cell therapy, in PDAC is limited due to the dense
desmoplastic stroma and immunosuppressive tumor microenvironment (TME). This project aims to develop and
explore novel approaches to enhance the effectiveness of ACT for PDAC. The F99 phase (Aim 1) focuses on
assessing the efficacy of mesothelin-directed CD26+CD4+ CAR T cells in murine PDAC models. CD26+CD4+ T
cells have shown favorable stem-memory phenotypes and polyfunctional cytokine secretion capabilities. We
hypothesize that CD26 on CAR T cells plays an active role in reshaping the TME through its enzymatic activity,
which functionally alters immunosuppressive peptides. Our approach involves using congenic markers to
distinguish between donor and host cells, allowing for detailed immune profiling via flow cytometry. We will
assess tumor growth over time using luciferase-expressing PDAC cells and bioluminescence imaging. To
elucidate the importance of CD26 enzymatic activity, we will employ systemic inhibition using sitagliptin and
evaluate its impact on CAR T cell efficacy, persistence, and memory phenotypes. Additionally, we will investigate
the potential synergistic effects of co-infusing CD26+CD4+ CAR T cells with CD8+ T cells to determine whether
multifaceted T cell-mediated interactions enhance cellular therapy efficacy. The K00 phase (Aim 2) builds upon
my predoctoral work in ACT development to characterize the impact of the microbiome on ACT outcomes in
PDAC. Recent evidence suggests that the gut microbiome significantly influences the efficacy of cancer
immunotherapies; I therefore seek to identify specific microbial signatures associated with improved responses
to ACT. I will employ 16S rRNA sequencing and metagenomic analysis to characterize the gut microbiome
composition in PDAC mouse models undergoing different adoptive cell therapies. I will also investigate the
efficacy of ACT in response to different microbiomes, manipulated with antibiotics or by addition of defined
microbial consortia into germ-free mice. Mechanisms by which the microbiome influences immune cell function
will be interrogated both in vitro and in vivo. Based on these findings, I aim to develop novel microbiome-
modulating strategies, such as targeted prebiotics or probiotics or novel engineered ACT strategies, to enhance
the efficacy of adoptive cell therapies in PDAC. This research has the potential to significantly advance our
understanding of adoptive cell therapies for PDAC and other solid tumors. By unraveling the intricacies of CD26-
mediated immunomodulation (F99) and exploring the role of the microbiome in ACT treatment outcomes (K00),
we aim to develop more effective strategies for overcoming the challenges posed by the PDAC tumor
microenvironment. Ultimately, this work could lead to the development of novel, more potent adoptive cell
therapies in pancreatic cancer, offering new hope for patients facing this devastating disease.

Public health relevance
Project Narrative Most patients with pancreatic cancer do not respond well to therapy; even newer forms of therapy, in which the patient’s immune system is redirected to fight cancer from within, are usually ineffective against this aggressive disease. We seek to improve these immune-based therapies by selecting a specific subset of helper T cells, which are immune cells that express high levels of a molecule called CD26, and engineering these CD26 helper T cells to recognize a marker on the surface of pancreatic cancer cells for targeting and killing (F99). The microbes and bacteria that are naturally present in our bodies interact with our normal immune systems all the time, so we want to see how specific types of bacteria can influence immune-based therapies as well and will test whether helpful bacteria can be enhanced to improve the effectiveness of immune-based therapies for pancreatic cancer (K00).